Use of Bacterial Biofilm Disrupting Antibodies to Prevent and Treat Periprosthetic Joint Infection

PROJECT SUMMARY……………………………………………………………………………………………………
Periprosthetic joint infection (PJI) describes infection on and around an orthopedic implant used for joint
replacement. PJI is the most common devastating complication following joint replacement surgery. Treatment
of PJI often involves multiple revision surgeries as well as months to over a year of antibiotics. Current PJI
treatment strategies can have high failure rates, and further adverse outcomes from PJI include amputation or
death, with mortality in patients with PJI often over 10%. There is a critical need for enhanced methods to
prevent PJI and eradicate PJI once it has occurred. The most problematic unaddressed feature of PJI is
bacterial biofilm formation, which is a composition of substances secreted outside the bacterial cell that
provides a protective barrier against antibiotics and the host immune response. Bacterial biofilm formation, and
its influence on antibiotic and immune mediated bacterial clearance, occurs as early as hours following
infection. Outside the context of the orthopedic setting and PJI, a novel biofilm disrupting antibody (anti-DNABII
monoclonal antibody) has been developed. Validation of the efficacy of this antibody has been rigorously
tested in vitro, as well as animal models of otitis media (middle ear infection) and pneumonia and has been
demonstrated to diminish bacterial biofilm biomass by over 90% and enhance clearance of infection in vivo.
This anti-DNABII antibody is currently undergoing Phase 1 clinical trials in patients with bacterial pneumonia. In
this investigation, we will test anti-DNABII antibody in a mouse model of PJI using the most common clinical
cause of PJI, Staphylococcus aureus (S. aureus). Aim 1 will determine if implants coated with anti-DNABII
antibody can prevent implant biofilm in a mouse model of PJI. We hypothesize that localization of anti-DNABII
antibody to the implant, at the time of implant surgery and bacterial inoculation, will substantially diminish S.
aureus bacterial biofilm formation on the implant in the mouse PJI model. Aim 2 will determine if anti-DNABII
antibody eradicates persistent S. aureus infection in a mouse model of PJI. We hypothesize localized delivery
of anti-DNABII antibody through intra-articular injection to the infected surgical site, starting at day 7 following
implant placement and S. aureus inoculation, will result in collapse and disintegration of the bacterial biofilm
and allow complete eradication of infection in combination with antibiotic treatment in the mouse PJI model.
Data generated from this investigation will inform future pre-clinical as well as clinical studies to investigate the
ability of anti-DNABII antibody to eradicate or prevent PJI.

Public health relevance
PROJECT NARRATIVE___________________________________________________________________ Periprosthetic joint infection (PJI) is the most common cause of acute joint replacement failure and contributes to substantial morbidity, mortality, and hospital costs following joint replacement surgery. Bacterial biofilm formation makes PJI extremely resistant to antibiotics and the host immune response, which leads to high PJI treatment failure rates. We will test a biofilm disrupting antibody (anti-DNABII monoclonal antibody) as a method to prevent and treat PJI in a well validated mouse model of PJI for enhancement of PJI prevention and treatment strategies.